Development of Neurons

DESCRIPTION (provided by applicant): Our perceptions, behaviors, emotions, memories and intelligence depend on the appropriate synthesis and release of specific neurotransmitters in the brain. Since the award of the Nobel Prize for the discovery of chemical synaptic transmission, it has been thought that transmitters are fixed and invariant throughout life and that the plasticity of the nervous system consists of changes in the strength and number of synapses. We have discovered that activity plays a key role in transmitter specification in the developing spinal cor, regulating the specification of glutamate, an excitatory transmitter, versus GABA, an inhibitory transmitter. This discovery contrasts sharply with the current general view of transmitter constancy and identifies another way that the nervous system can adapt to the environment. These findings lead to several related questions: 1) Is activity-dependent transmitter respecification cell-autonomous in the embryonic Xenopus spinal cord? Do patterns of calcium spike activity regulate transmitter identity in the neurons generating them or does regulation depend on the activity of neighboring cells? 2) Does activity-dependent transmitter respecification involve the action of secreted factors? If so, what are they? 3) What is the molecular signaling cascade that drives transmitter respecification? How is calcium spike activity linked to transmitter switching? The immediate goals of this research are to test specific hypotheses about the mechanisms by which natural, spontaneous electrical activity regulates transmitter specification in the vertebrate CNS. We expect to provide information about the cellular and molecular machinery that governs transmitter specification during development. The long term goals are to use this understanding of the molecular pathways of activity-dependent transmitter respecification to develop new tools useful for treating disorders of the nervous system such as schizophrenia and depression, to which environmental stimuli contribute and in which neurotransmitter expression is altered.

Public health relevance
Appropriate expression of neurotransmitters and their receptors is essential for the normal function of the nervous system. We have discovered that activity plays a key role in transmitter specification in the developing spinal cord, regulating th specification of glutamate, an excitatory transmitter, versus GABA, an inhibitory transmitter. Here we propose to determine the molecular mechanism regulating this process.